Pathophysiology, diagnosis and biofeedback therapy in fecal incontinence using fecobionics

ABSTRACT
Fecal incontinence (FI) affects 1 in 7 Americans with a rising incidence that poses a major healthcare burden.
Its pathophysiology is poorly understood and consequently there is dearth of effective treatment(s). A critical
barrier to progress has been the lack of comprehensive, physiologically-relevant and practical diagnostic test
for identifying the underlying mechanism(s). Current tests provide either incomplete or conflicting information
that do not correlate with symptoms and treatment outcomes. Our goal is to determine the role of anorectal
muscles in maintaining continence and facilitating defecation, and how anorectal malfunctions can cause FI by
using a novel technology called Fecobionics (an electronic simulated stool) to evaluate its diagnostic and
therapeutic utility. Fecobionics has the consistency and shape of normal stool that can record pressures, cross-
sectional area, orientation, and viscoelastic properties of the anorectum. With heavily upgraded hardware,
software and graphical user interface, the new Fecobionics device map the geometric profiles during evacuation
and relate them to simultaneous changes in pressures (forces) and bending. Our central hypothesis is that the
movement of the Fecobionics device through the anorectum will provide unknown and new mechanistic insights
on anorectal physiology including intraluminal pressure changes, anal muscle length-tension relations,
resistance generated during movement of the surrogate stool and its deformability, as well as distensibility of the
anal sphincters in normal subjects and FI patients. This multidimensional data could facilitate new treatments for
FI. Accordingly, our Specific Aims are to: 1) Determine the length-tension properties of the anal sphincters
using Fecobionics in normal subjects and FI patients during anal distension and during simulated evacuation. 2)
Elucidate the pathophysiological characteristics and biomechanical properties of individual muscle components,
external, internal anal sphincter and puborectalis muscle using the Fecobionics device and comparing FI patients
with normal subject controls; and 3) Evaluate the use of Fecobionics as a biofeedback treatment (BT) and
monitoring tool in FI patients to determine the predictors for treatment success, by performing a randomized
controlled trial of Fecobionics-assisted Biofeedback Therapy (FBT) versus conventional Office-based
Biofeedback Therapy (OBT). Our proposal seeks to shift current FI research by testing a stool surrogate for
performing BT as opposed to a thin manometry probe and examine the multi-dimensional physiologic changes
(i.e., pressure, deformability, biomechanics, vectoral and topographic changes) as well as clinical outcome
following BT. The unique aspect of our proposal is to simulate stooling with a wireless bionics device and
examine in detail the mechanistic underpinnings in health and in FI patients. The impact of our project is to
provide new mechanistic understanding of anorectal function and pathophysiology in FI and validate the clinical
utility of a novel, highly integrated device for diagnostics and facilitation of biofeedback therapy with an
unprecedented graphical feedback to the patient of mechanosensory actions.

Public health relevance
NARRATIVE Fecal incontinence is a common problem, yet poorly diagnosed and treated. Our goals are to determine the role of anorectal muscles in maintaining continence and defecation, and how their malfunction(s) can cause FI by using a new technology (i.e., Fecobionics) and novel methodology.